Brain Network Mechanism of Fast and Slow Recoveries in Pharmacologically and Pathologically Induced Unconsciousness

Project Summary/Abstract
It is not understood why some patients recover from unconsciousness (anesthesia and coma) at a relatively
faster rate while others show prolonged recovery times; or do not recover at all from coma. Traditionally, the
approaches to fill this critical gap in our knowledge has focused on the subcortical nuclei linked to the states of
arousal (sleep, wake, anesthesia), but recent neuroimaging studies suggest that consciousness, rather than
being a product of a localized neural circuit, is likely to be an emergent phenomenon resulting from complex
interactions between spatially and temporally distributed activity of neurons across the brain. Accumulating
evidences suggest that criticality, an optimal balanced state between order and disorder, in the brain presents
highly informative, integrative, and sensitive state such that it has been suggested as a necessary condition for
the emergence of consciousness. We recently demonstrated that the level of consciousness during general
anesthesia correlates with the degree of brain criticality, and similar findings have been reported from other
groups. Therefore, we hypothesize that facilitating the brain networks towards criticality will accelerate the
recovery of consciousness from anesthesia and disorders of consciousness. However, controlling criticality is a
challenging problem and has not been attempted in the brain networks. Using a novel approach, we will apply
explosive synchronization, a phenomenon wherein a small perturbation to a network can lead to an abrupt state
transition through global network synchronization, to control brain criticality. By reconceptualizing the mechanism
of explosive synchronization as a mechanism of criticality transition, we will be able to systematically study fast
and slow transitions in brain criticality and the effect on state transitions. Our long-term goal is to use the
principles of physics to develop neuroscientific foundations for the strategies to accelerate the recovery from
anesthesia and coma. The objective of the proposed studies is to explore explosive synchronization as a
mechanism for the recovery of consciousness. The rationale for the proposed research is that characterization
of the relationship between criticality transition and fast/slow recovery of consciousness will provide insights into
the fundamental network level mechanisms that govern fast and slow state transitions and will also help inform
translational studies aimed at accelerating recovery from unconsciousness. We will pursue the following two
specific aims: 1) Determine the relationship between explosive synchronization in the brain networks and the
recovery of consciousness from anesthesia and coma. We will use computational modeling to identify the brain
network conditions linked to fast and slow state transitions, and test the model predictions using empirical data
from anesthesia (human and rat) and coma (human) studies. 2) Determine the causal effect of changes in brain
network criticality on the recovery of consciousness from anesthesia in rat. We will use our recently reported rat
models of fast and slow recovery of consciousness from anesthesia to investigate a causal relationship between
recovery of consciousness and brain criticality.

Public health relevance
Project Narrative This research proposal is relevant to public health and the mission of NIGMS because it aims to identify a systems level mechanism that underlies wide differences in recovery profiles from states of anesthesia and coma. This study will have a positive impact on the clinical care by providing physical and neuroscientific foundations to monitor and accelerate the recovery of consciousness from anesthesia and disorders of consciousness.